EFFICACY OF MISOPROSTOL TREATMENT OF MASTOCYTE ACTIVATION DISORDER

This study is to assess the efficacy of treatment with misoprostil to inhibit episodes of systemic mastocyte activation in patients with idiopathic anaphylactoid attacks, aspirin-induced anaphylactoid attacks, and systemic mastocytosis. This has been a long-term on going study which we continue to track the patients. It is hopeful that with such long term tracking, new treatment regimen will be developed for these patients.